Software tools for creating standardized multimodal EHR datasets for advancing ophthalmic research using AI

PROJECT SUMMARY
Ophthalmology heavily relies on multimodal electronic health record (EHR) data, such as clinical notes,
structured data, and imaging, to diagnose, treat, and monitor patients. However, inconsistencies in
documentation and the lack of standardized datasets pose significant challenges to leveraging this data for
research and clinical applications. Developing robust AI-driven tools that integrate and standardize multimodal
EHR data can transform ophthalmic research and improve patient outcomes.
This project focuses on advancing the development of AI models, including natural language processing (NLP)
and large language models (LLMs) to address these challenges. Specifically, the project will develop tools to
enhance data quality, extract key clinical concepts, and standardize multimodal datasets for ophthalmology
research. These tools will support tasks such as predicting disease progression, improving clinical workflow
efficiency, and enabling data harmonization for multicenter research.

Public health relevance
PROJECT NARRATIVE Ophthalmology relies on multimodal EHR data, but inconsistencies and lack of standardization impede its effective use for research and clinical care. AI-driven tools leveraging NLP and LLMs can address these challenges by improving data quality, extracting key clinical concepts, and standardizing datasets. These advancements will facilitate more accurate disease progression prediction, streamlined clinical workflows, and effective data harmonization, ultimately advancing clinical research and enhancing patient care.